Phthalate and bisphenol exposure in relation to infant reproductive development during minipuberty

Project Summary/Abstract
Minipuberty, a brief window during the first six months of life when reproductive hormones surge, may be a
particularly vulnerable period for endocrine disruption by phthalates and bisphenols, endocrine-disrupting
chemicals (EDCs) with both estrogenic and anti-androgenic activity that infants are highly exposed to via
disposable diapers, wipes, baby lotions, shampoos, and plastic baby bottles. Exposure to EDCs during critical
periods of early development can alter ovarian and testicular tissue, which may influence future reproductive
development and function, including timing of pubertal maturation and subsequent fecundity. To date, only three
cross-sectional studies have examined endocrine disruption during minipuberty, and while results have differed,
all have found some associations between bisphenols and/or phthalates and infant reproductive hormones. None
has examined associations between EDC exposure during minipuberty and anogenital distance (AGD), a
measure that has been associated with maternal prenatal bisphenol and phthalate levels as well as adult
reproductive health outcomes. The current project, nested within the New York University Children’s Health and
Environment Study (NYU CHES), an ongoing prospective birth cohort, will include 480 full-term singleton infants
whose mothers have provided repeated urine samples during pregnancy and examine both in utero and
concurrent chemical exposure in relation to hormones and AGD in minipuberty. During 2 and 4-month postnatal
study visits, urine and blood will be collected from the infants, and urine and breast milk will be collected from
their mothers. Infant AGD will be measured by trained study staff members at birth and during both postnatal
study visits. Maternal prenatal urine, child postnatal urine, and maternal breast milk will be screened for
bisphenols and phthalates. Unlike prior studies that have focused only on chemicals for which analytic standards
are available, we will examine both known and unknown bisphenols and phthalates using a novel approach that
will leverage advanced computational methods for analyzing non-targeted high-resolution mass spectrometry
(HRMS) data. Concentrations of nine reproductive hormones and two proteins will be quantified in infant serum
via high performance liquid chromatography-electrospray ionization-tandem mass spectrometry. Aims include:
1) evaluating longitudinal associations of maternal prenatal urinary bisphenol and phthalate levels with infant
reproductive hormone concentrations during minipuberty, 2) quantifying associations of infant urinary bisphenol
and phthalate levels with infant reproductive hormone concentrations during minipuberty, and 3) examining joint
effects of infant chemical and hormone levels on AGD during minipuberty. We hypothesize that phthalate and
bisphenol exposure during both prenatal and postnatal periods will be associated with infant reproductive
hormones, that both chemicals and hormones will be associated with AGD, and that associations will be sexually
dimorphic. Regression analyses will incorporate advanced statistical methods for the reduction of high-
dimensional data and for analyzing effects of chemical mixtures.

Public health relevance
Project Narrative Minipuberty is a brief period in the first six months of life when infant reproductive hormones surge—in some cases to levels nearly as high as in puberty and adulthood—and it is believed that this surge may be important for developmental programming of the reproductive system, potentially influencing pubertal timing and future ovarian and testicular function. This study will examine whether exposure to phthalates and bisphenols— chemicals commonly found in plastics, food packaging, household cleaners, cosmetics, and baby products— alters infant reproductive hormone levels and anogenital distance, an indicator of reproductive development. In the process, using a novel method of biospecimen analysis, we will seek to identify previously unmeasured phthalates and bisphenols that may have endocrine-disrupting properties.